Linguistic and Neural Synchrony During Co-Rumination as Interpersonal Mechanisms of Depression in Adult and Adolescent Dyads

PROJECT SUMMARY/ABSTRACT
Interpersonal dysfunction is an intractable problem in depression that strongly predicts depression vulnerability
and chronicity. Clarifying markers of interpersonal dysfunction and its biobehavioral mechanisms are
prerequisites to developing theoretically based and biologically informed interventions able to improve functional
outcomes. An established marker of interpersonal dysfunction is co-rumination–i.e., excessively discussing
personal problems and dwelling on negative affect in dyadic relationships–a construct linked to worsened
depression severity in both dyadic partners. However, the biobehavioral processes that unfold during co-
ruminative interactions remain unclear, precluding the identification of precise intervention targets. The proposed
K99/R00 project tests whether temporal alignment (i.e., synchrony) in language and neural oscillations
between close friends is a mechanism of co-rumination, given synchrony’s key role in communication and
bonding. The overall hypothesis is that linguistic and neural synchrony during a laboratory problem discussion
task (K99 and R00) and smartphone communication (R00) mediate the association between co-rumination and
depression, using simultaneous dual-subject EEG recordings (hyperscanning) and mobile sensing (to acquire
smartphone communication; R00 only). 76 adults (K99; 50% female, 18-40 yrs) and 110 adolescents (R00; 50%
female, 14-17 yrs) with major depression and one of their same-sex friends will be recruited. Aims will test
whether linguistic and neural synchrony are associated with in-lab co-rumination (Aim 1) and concordance in
depression symptoms (Aim 2), as well as whether linguistic synchrony in smartphone communication is
associated with in-lab co-rumination and depression (Aim 3). Both the K99 and R00 will additionally explore
whether sex moderates the association of synchrony with co-rumination and depression. To achieve these aims,
the proposed career development plan will build on Dr. Li’s previous training, with four goals to enhance her
trajectory towards becoming an independent investigator: (1) apply multimethod RDoC approaches to studying
mechanisms of psychopathology, (2) conduct mobile sensing and dyadic-level natural language processing
analysis, (3) conduct EEG hyperscanning and dyadic-level EEG time-frequency analysis, and (4) grantsmanship,
lab management, and interdisciplinary collaboration requisite to run a successful, independent laboratory.
Training will be accomplished through direct mentorship from experts in developmental psychopathology,
neuroscience, and computer science and formal coursework from centers and institutes at Northwestern
University. Data obtained in this project will (a) explicate the biobehavioral mechanisms of interpersonal risk
factors for depression, (b) lead to future R01 applications on the longitudinal predictive utility of linguistic and
neural synchrony for depression, and (c) give Dr. Li the expertise in integrating innovative methodological and
computational tools to study the transdiagnostic, interpersonal mechanisms of psychopathology.

Public health relevance
PROJECT NARRATIVE Interpersonal dysfunction is a major contributor to the immense personal and societal cost of depression, undermining patients’ capacity for employment, independent living, and maintaining meaningful relationships. The goal of the proposed project is to identify the biobehavioral mechanisms of co-rumination (an established marker of interpersonal dysfunction in depression characterized by excessively discussing personal problems and dwelling on negative affect), by testing the role of (a) linguistic and neural synchrony between dyadic partners using simultaneous dual-subject EEG recordings and (b) mobile sensing of naturalistic communication on the smartphone. This innovative, multimethod project will identify precise linguistic patterns and brain circuits linked to depression risk at the dyadic level, which can be targeted in future interventions to improve functional outcomes.